Academic Leadership Award - The Translational Rehabilitation in Geroscience Initiative

ABSTRACT
The long-term objective of this NIA Leadership Award is to create a robust, highly visible, innovative, and
sustainable “interdisciplinary translational rehabilitation Geroscience-focused research and education program”
as a cornerstone of research excellence at BU. This includes both bench to early-stage clinical investigations and
the reverse in highly prevalent disease-specific conditions such as arthritis, stroke, and frailty. To accomplish its
long-term objective, this Leadership Award will carry out three specific aims. Aim#1: Expand the knowledge in
translational rehabilitation and Geroscience by catalyzing research and education through the establishment of
a cohesive infrastructure, the Translational Rehabilitation in Geroscience Initiative (TRIG Initiative). Aim#2:
Create an exceptional research and educational environment that fosters development of successful
multidisciplinary translational rehabilitation Geroscience-based investigators with customized expertise in
preclinical and clinical science. Aim#3: Establish a pilot grant program to support the most promising
translational rehabilitation Geroscience-focused studies. These specific aims will be achieved through the
candidate’s leadership of the TRIG Initiative, the breaking down of silos, and the meaningful collaboration with
the multitude of existing resources for interdisciplinary research and education. In support of Aim 1, the TRIG
Initiative will be created through active recruitment of an interdisciplinary group of scientists, clinicians, and
trainees across Boston’s academic and clinical institutions and regular discussions on translational rehabilitation
research and Geroscience themes. In support of Aim 2, interdisciplinary partnerships with key stakeholders
across the entire university and Boston community will be developed to offer rich research and educational
opportunities for the career development of students and investigators with tailored expertise in translational
rehabilitation science and Geroscience (e.g., seminars, workshops, collaborative laboratory meetings, courses.)
In support of Aim 3, an annual pilot grant program will fund multidisciplinary, translational research that spans
between basic and early-stage clinical sciences. The candidate is an internationally recognized muscle
physiologist, a leading authority on mechanisms contributing to sarcopenia, and established the mouse frailty
phenotype assessment tool in order to conduct translational research to tease out the etiology of frailty. The
candidate has the necessary scientific expertise, leadership skills, clinical and research training, and mentoring
and teaching experience to lead the TRIG Initiative, implement new activities and curriculum, and accomplish
the stated aims of this proposal. Through the support of this NIA K07 Leadership Award and leveraging an
impressive array of valuable research and educational resources through BU and the Boston area, the TRIG
Initiative envisions active interdisciplinary faculty and trainees engaging in collaborative research, publications
and education, building translational rehabilitation Geroscience-based research that culminates in program
project grant submission and awards.

Public health relevance
NARRATIVE This NIA Leadership Award is to support Dr. Thompson’s efforts to create a robust, highly visible, innovative, and sustainable “interdisciplinary translational rehabilitation Geroscience-based research and education program” as a cornerstone of research excellence at Boston University.